Defining the Neurological Substrates of Proximal Upper Extremity Motor Control and Recovery After Stroke

PROJECT SUMMARY
Strokes commonly damage motor pathways in the brain which leads to “hemiparesis”, the collective term given
to the syndrome of motor dysfunction after stroke. Upper extremity hemiparesis is comprised of both loss of
abilities (negative signs— weakness and loss of dexterity or fractionated motor control) and intrusion of abnormal
movements (positive signs— spasticity, abnormal resting postures, and synergies). Recent work from our group
and others shows that components of motor hemiparesis are dissociable: they can be separated and each map
onto different and specific brain pathways. In this proposal, we focus on one specific component of post-stroke
hemiparesis: proximal upper extremity motor control. Proximal upper extremity motor control can be measured
as the ability to individuate and coordinate shoulder and elbow movements. We ask (i) where does proximal
upper extremity motor control localize in the post-stroke brain? (ii) can we improve motor control with a specific
form of targeted, high-dose, high-intensity therapy? And (iii) does therapy lead to corresponding changes in
anatomy and physiology of brain pathways? Our central hypothesis is that intensive, targeted training improves
proximal upper extremity motor control and induces corresponding anatomical and physiological changes of the
corticospinal tract. To test this hypothesis, we will conduct three specific aims: (1) Determine baseline
relationships between the corticospinal tract and proximal upper extremity motor control, (2) Define changes in
proximal upper extremity motor control induced by targeted rehabilitation training, and (3) Define changes in
corticospinal tract anatomy and physiology induced by targeted rehabilitation training. We leverage a clinical trial
design of N = 50 patients with moderate-severe hemiparesis randomized to two groups: Arm Basis Training (a
protocolized form of occupational therapy targeting motor control) versus usual care. Before and after six weeks
of therapy, all patients will undergo kinematic assessment of motor control, diffusion magnetic resonance
imaging to assess corticospinal tract axon density, and transcranial magnetic stimulation to assess corticospinal
excitability. Dr. Lin, an acute care neurologist with neurorehabilitation and neuroscience training and the Director
of the MGH Neurorecovery Clinic, will lead the project and bring together a world-class team of investigators and
consultants, supported by the rich and multidisciplinary environment at Massachusetts General Hospital, Harvard
Medical School, and collaborating institutions. This project is a mechanistic and hypothesis-driven investigation
of the neuroanatomic and neurophysiologic signatures of a specific component of hemiparesis, proximal upper
extremity motor control, and its response to targeted rehabilitation. The unique integration of kinematics,
neuroanatomy, and neurophysiology in patients after stroke will transform stroke rehabilitation with a precision
approach that targets brain structure and function.

Public health relevance
PROJECT NARRATIVE Difficulty moving the arm is very common and a major cause of disability after stroke. Although rehabilitation therapies (i.e., occupational and physical therapy) are the most common treatments used to improve arm motor function, it remains unknown how therapy actually changes brain pathways. This project seeks to generate fundamental knowledge about brain pathways that allow people to move their arm after stroke and how these pathways change with rehabilitation; we expect this knowledge to translate to new therapies to reduce stroke- related disability.